Oklahoma ACE: Molecular Destruction of Autoimmune Disease to Aid Clinical Trail Success

Project Summary
The Oklahoma Autoimmunity Center of Excellence aims to understand autoimmune disease biology
through interdisciplinary, collaborative research integrating clinical and basic questions. Prior Oklahoma
Autoimmunity Center of Excellence (ACE) work as both a Basic and Clinical ACE has significantly advanced
our understanding of autoimmune disease genetics, development, flare, and heterogeneity. The Oklahoma
ACE has also contributed to eight ACE trials, serving as a Protocol Chair and/or a lead recruitment site for
five while also building unique patient cohorts and data/sample collections from diverse urban, rural, and
minority communities. Through this currently funding of the UM1 Clinical ACE submission, the Oklahoma
ACE strives to deconstruct the molecular heterogeneity of autoimmune diseases to implement more
effective clinical trial designs, optimize biologically relevant treatment selection, and improve disease
understanding. The Oklahoma ACE consists of a primary clinical project, alternate clinical project,
collaborative project and Administrative Core. In addition, the Oklahoma ACE was selected to serve as the
ACE Biorepository Core and this supplement focuses on adding equipment to the core to improve
efficiency, improve sample, and better manage biospecimens collected from the ACE clinical trial network.
New with this renewal, we proposed our Oklahoma Medical Research Foundation College of American
Pathologists (CAP)-certified Biorepository to serve as the ACE Biorepository Core, leveraging decades of
experience as an autoimmune disease biorepository, dedicated personnel, standard policies/procedures, and
high biobanking standards. Due to expanding needs of the network and to improve energy efficiency and
decrease liquid nitrogen usage, this application requests eighty percent of a new, large, floor model, vapor-
phase liquid nitrogen storage tank for storage of current and future ACE samples. The Oklahoma Medical
Research Foundation is also committing funds to this purchase, along with the ongoing operational expenses,
preventive maintenance, service agreements, and room upgrades to monitor employee safety and oxygen
content of the liquid nitrogen facility storage room which is adjacent to the OMRF tornado shelter. In addition,
this application is requesting modest supplemental funding to purchase small equipment and associated racks
and tubes needed for the implementation of use for current and new ACE biospecimens in the newly acquired
fully contained, robotic -80 Bio-Arc storage system which is currently being constructed in an adjacent lower-
level location to the liquid nitrogen storage facility.

Public health relevance
Project Narrative Autoimmune diseases afflict up to 12% of the US population and remain a common cause of morbidity and early mortality. Non-toxic, effective therapeutics often do not exist. This program focuses on identifying molecular homogeneous subsets of patients to aid trials, inform treatment and improve patient outcomes and the requested supplement items allow more efficient and effective storage and central management of samples from Autoimmunity Center of Excellence study participants.